Ehrlichia modulation of RNA splicing to influence KIRREL1-regulated Hippo signaling

ABSTRACT
Ehrlichia chaffeensis is a Gram-negative, obligately intracellular bacterium and the etiologic agent of human
monocytotropic ehrlichiosis (HME), an emerging, life-threatening, tick-borne zoonosis. E. chaffeensis.
preferentially infects mononuclear phagocytes and survives intracellularly by subverting innate immune defenses
mediated in part by tandem repeat protein (TRP) effectors. Within the last decade, our laboratory has identified
a multitude of molecular ehrlichial TRP-host interactions, many that are new to science, illuminating the breath
and complexity of pathogen-host interaction dynamics that occur during infection. Notably, we have investigated
TRP effector interactions with host cell posttranslational modification (PTM) machinery, transcription factors and
epigenetic modifiers and immune and developmental signaling pathways. We have shown that TRP120 directly
interacts with multiple eukaryotic proteins involved in transcription and post transcriptional regulation, including
hnRNPA2B1, an RNA splicing factor. Understanding the molecular strategies E. chaffeensis has evolved to
manipulate RNA splicing factors such as hnRNPA2B1 to modulate genes associated with regulation of cellular
signaling and other responses linked to innate immunity is an unexplored gap in our knowledge. The long-term
goal of this project is to understand post transcriptional regulatory mechanisms exploited by E. chaffeensis to
modulate macrophage innate defenses. The objective of this proposal is to investigate RNA splicing factor
hnRNPA2B1 as a substrate of TRP120 HECT E3 Ub ligase activity and determine the effects of pre-mRNA AS
of KRILLEL1 on the Hippo/YAP pathway activity during infection. We hypothesize that E. chaffeensis TRP120
ubiquitinates nuclear hnRNPA2B1 for degradation to modulate KIRREL1 pre-mRNA AS to maintain YAP
activation and to promote infection. This research will promote the rational development of innovative and
mechanistically targeted therapeutics to combat intracellular pathogens that manipulate RNA splicing for
infection. Our hypothesis will be examined with the following specific aims: Aim 1 will investigate hnRNPA2B1
as a substrate of E. chaffeensis TRP120 HECT E3 Ub ligase. Aim 2 will investigate functional role of hnRNPA2B1
in regulating mRNA stability by AS during infection; and Aim 3 will investigate pre-mRNA AS of KIRREL1 as a
mechanism to regulate Hippo/YAP signaling. The significance of this research is also based on defining
mechanistic strategies, whereby intracellular pathogens with small genomes and a limited number of effector
proteins target host RNA regulatory proteins to manipulate host innate defenses for infection through regulation
of evolutionarily conserved signaling pathways. In this investigation, we will begin to define the molecular and
cellular mechanisms E. chaffeensis has evolved to modulate cell signaling and host innate defenses regulated
by RNA splicing factors.

Public health relevance
Narrative Ehrlichia chaffeensis is an obligately intracellular bacterium that replicates in mononuclear phagocytes by secreting multifunctional effector proteins that activate and regulate evolutionarily conserved host cell signaling pathways through molecular mimicry and post translational modifications, respectively. This investigation will define a pathogen molecular strategy that promotes host cell survival and E. chaffeensis infection by manipulating RNA splicing factors to regulate the Hippo signaling pathway. Understanding pathogen-directed manipulation of RNA splicing factors and the impact on cellular infection will provide potential new therapeutic targets for intracellular bacteria.